Structural Racism and Adverse Birth Outcomes in the US South: A Multigenerational Perspective (Diversity Supplement)

ABSTRACT
Candidate: The candidate is an epidemiologist with expertise in environmental influences on maternal and
child health (MCH). She is applying for the NIMHD supplement to promote diversity in health-related research
(diversity supplement) under parent grant, “Structural racism and adverse birth outcomes in the US South: A
multigenerational perspective” (1R01MD016046-01). The candidate seeks specialized training in social
epidemiology, environmental justice advocacy and statistical modeling methods to support her development
into an independent researcher who examines relationships between social and environmental drivers of
adverse birth outcomes. Her goals are to use an interdisciplinary approach to improve understanding of the
complex factors and the resulting pathways that contribute to health disparities and ultimately, partner with
communities to advocate for research-informed environmental justice solutions to address drivers of MCH
health disparities. Research context: This work extends the scope of the parent grant by examining racial
differences in associations between multi-generational air pollution exposure, which may in part result from
discriminatory practices stemming from structural racism, and adverse birth outcomes. Structural racism is
reported to be a key driver of the uneven distribution of air pollution and may play a role in observed racial and
ethnic disparities in adverse birth outcomes. Policies such as redlining, an outdated policy used to classify
neighborhoods and subsequently used as an investment eligibility measure by lenders, may be a driving factor
in the hypothesized air pollution and adverse birth outcomes relationship. Although redlining ended in 1968, its
impact has persisted and is evidenced by associations between redlined neighborhoods and the siting of
pollution sources such as industrial facilities and roadways. Research objectives: This work will complement
the parent grant by adding another measure of structural racism and allow for a broader understanding of its
contributions to disparities in adverse birth outcomes. Research plan: Data from the parent study (South
Carolina multigenerational linked birth data from 1989-2020) will be used to generate census tract level
prenatal air pollution data for grandmothers and mothers to examine associations between multi-generational
air pollution exposure and adverse birth outcomes among Non-Hispanic White and Non-Hispanic Black
families. Career development goals: Through didactic and experiential activities, this work will enable the
candidate to acquire specialized skills in social epidemiology, environmental justice and statistical modeling
methods to support her development. Environment: The candidate will conduct the proposed activities in a
setting supported by eminent leaders in social epidemiology, environmental epidemiology, and biostatistics.
Exceptional resources at the University of Michigan and the School of Public Health ensure that the candidate
can successfully implement the proposed work and lay the foundation to acquire future R01 funding to conduct
independent research on environmental and social drivers of disparities in adverse birth outcomes.

Public health relevance
PROJECT NARRATIVE Disparities in maternal exposure to air pollution may be influenced by structural racist policies and may contribute to higher rates of adverse birth outcomes among Non-Hispanic Blacks compared to Non-Hispanic Whites. To understand the impact of these policies on air pollution distribution and persistently high rates of adverse birth outcomes among non-Hispanic Blacks, investigating multigenerational associations is crucial. A framework that explores the role of structural racism may inform the development of comprehensive intervention strategies that focus on policy and increased support for research that involves stakeholders in affected communities as investigators.